Targeting mitochondrial RNA methylation in high-risk acute myeloid leukemia

Project Summary
Acute myeloid leukemia (AML) is one of the most aggressive types of hematopoietic malignancy. Despite
treatment advancements, over 70% of AML patients remain incurable. Individuals with MLL rearrangements (MLL-
r, 5-10% of AML) and/or FLT3 internal tandem duplications (FLT3ITD, 20-25% of AML) experience a worse
prognosis than others. Leukemia stem/initiating cells (LSCs/LICs) are recognized as the root cause of AML
initiation, progression, and relapse, and these cells heavily depend on mitochondrial oxidative phosphorylation
(OxPhos) for energy production. Thus, targeting mitochondrial metabolism emerges as an attractive strategy to
eliminate LSCs/LICs for a potential cure. Intriguingly, the mitochondrion possesses its own circular genome,
producing mitochondrial RNAs (mt-RNAs) which are decorated with various RNA modifications. Recent studies,
including our own, suggest that RNA modifications are critical for post-transcriptional gene regulation during
leukemogenesis, and targeting RNA modifications is a promising strategy to eradicate LSCs/LICs. However, the
biological and pathological roles of mt-RNA modifications in AML are still unclear. Additionally, it remains
unknown whether, and if so, how mt-RNA modifications coordinate mitochondrial-nuclear crosstalk for efficient
energy conversion. To bridge these knowledge gaps, we conducted large-scale data analysis and identified
mitochondrial methyltransferase like 17 (METTL17) as a novel vulnerability in AML. METTL17 knockout (KO)
decreases cytosine methylation in mt-12S ribosomal (r)RNA, resulting in 12S rRNA decay and mitochondrial
translation inhibition. This, in turn, suppresses AML growth, reduces OxPhos, and eliminates LSCs/LICs in MLL-
r and FLT3ITD AML. METTL17 KO-mediated OxPhos reduction further decreases acetyl-CoA and nuclear histone
H3 lysine 27 acetylation (H3K27ac), influencing nuclear gene expression, such as cyclin D3 (CCND3).
Pharmacological inhibition of METTL17 using an in-house inhibitor shows robust anti-AML efficacy. Therefore,
we hypothesize that METTL17, as a mitochondrial RNA methyltransferase, regulates OxPhos and sustains
LSC/LIC frequency, making it a potential `druggable' target for AML. We propose three Specific Aims to test our
hypothesis. Aim 1 will determine the functional importance of METTL17 in AML pathogenesis using mouse
models. Aim 2 will dissect the molecular mechanisms through which METTL17 promotes leukemogenesis. Aim
3 will evaluate the therapeutic impact of pharmacologically inhibiting METTL17 in AML. This study is innovative
and significant because it (i) advances our understanding of the pathological role of mt-RNA modification, (ii)
introduces a novel concept that mt-RNA methylation regulates retrograde mitochondrial-nuclear communication
via H3K27ac, and (iii) develops a specific and potent METTL17 inhibitor to improve outcomes of high-risk AML.

Public health relevance
Project Narrative: Acute myeloid leukemia (AML) patients with MLL rearrangements (MLL-r) and FLT3 internal tandem duplications (FLT3ITD) face a grim prognosis, and those AML cells heavily depend on a specific metabolic pathway called mitochondrial oxidative phosphorylation for generation of energy. This proposal aims to determine the role of METTL17 and mitochondrial RNA methylation in AML leukemogenesis, leukemia stem cell self-renewal, and metabolism, and delineate the mechanism(s) by which METTL17 orchestrates mitochondrial-nuclear communication to ensure efficient energy production. Furthermore, we will assess the therapeutic potential of our in-house METTL17 inhibitor, either alone or in combination with tyrosine kinase inhibitors, for treating high-risk AMLs with MLL-r and FLT3ITD.